MOLECULAR BIOLOGY OF NATURAL SCRAPIE

Specific data concerning the origin of prions in naturally occurring diseases is scant. Analysis of a human prion disorder, Gerstmann- Straussler syndrome (GSS has revealed a genetic manifestation. The disease behaves as an autosomal dominant linked, with a LOD score of 3.26 to a missense mutation of the prion protein gene (Hsiao et al., 1989). The objective of these studies is genetic and biochemical analysis of the development of scrapie disease in uninoculated sheep (i.e., the development of natural scrapie). Recent advances in the analysis of scrapie in laboratory rodents indicate that the major component of the scrapie prion is an aberrant isoform of a host glycoprotein, PrP. Additionally, the murine prion protein gene is tightly linked to our congruent with a locust (Prn-i) conferring relative susceptibility to laboratory scrapie infection. These insights suggest the analysis of parallel situations in sheep, as sheep harbor PrP genes and natural scrapie in sheep manifest as an autosomal recessive trait. Restriction fragment length polymorphism (RFLP) analysis will be used to test for linkage in pedigrees of natural scrapie between the scrapie trait, the s gene, and molecular probes including, but not necessarily restricted to the sheep PrP and histocompatibility antigen genes. In the event of PrP linkage, PrP genes from scrapie animals will be scrutinized for mutations that may predispose to the disease phenotype. Molecular cloning of a recessive "scrapie gene" will enhance and complement our understanding of natural prion diseases caused by dominant loci.